Efficacy of an integrated intervention to treat maternal depression and children’s behavior problems: A transactional perspective

PROJECT SUMMARY/ABSTRACT
At least 1 in every 10 children is exposed to maternal depression. Depression during adulthood is one
of the leading causes of disability, and when it occurs among women with children, depression also carries a 3-
to 6-fold increase in risk for offspring internalizing and externalizing behavior problems. Children's behavior
problems, in turn, elevate risk for subsequent maternal depression. The intertwined, transactional relations
between maternal depression and children's behavior problems call for integrated maternal-child mental health
interventions. However, integrated programs are scarce; adult and child mental health treatment programs
typically operate in narrow silos.
For example, Attachment and Biobehavioral Catch-up (ABC) is an empirically-supported 10-session
home-visiting parenting intervention that focuses on improving maternal sensitivity. ABC reduces children's
behavior problems, but it does not treat maternal depression. Similarly, Mothers and Babies is an empirically-
supported cognitive behavioral intervention for depression that focuses on improving mothers' negative
thinking and behavioral activation. Mothers and Babies reduces perinatal maternal depression, but it does not
treat children's behavior problems. Programs that address both maternal and child well-being are essential.
The proposed project is a randomized controlled trial to evaluate the efficacy of an integrated
intervention that dually treats maternal depressive symptoms and offspring behavior problems. Families (n =
240 mothers and their 2-to-4 year-old children) will be randomized to receive 10 sessions of ABC or 10
sessions of ABC+D in their home. ABC+D is an expanded version of ABC that additionally treats maternal
depressive symptoms using Mothers and Babies adapted for mothers of toddlers. The specific aims of this
proposed project are: Aim 1 – Evaluate the efficacy of ABC and ABC+D for reducing maternal depressive
symptoms and child behavior problems. We will also determine the extent to which reductions in maternal
depressive symptoms are a function of reductions in child behavior problems and vice versa, and Aim 2 – Test
whether the effects of ABC+D on maternal depression and child behavior problems are mediated through
decreases in maternal negative thinking, increases in maternal behavioral activation, and improved maternal
sensitivity. Primary outcomes are maternal depressive symptoms and children's behavior problems.
Our long-term goal is to contribute to precise interventions that are tailored to mental health problems at
the level of the family. The proposed project has high public health significance for reducing the burden of
maternal depression and children's behavior problems and for disrupting the transactional relations that
perpetuate them over time.

Public health relevance
PROJECT NARRATIVE Maternal depression influences the development of children's behavior problems and vice versa; however most interventions singularly address maternal depression or children's behavior problems rather than both. This project assesses the efficacy of an intervention that treats both mothers and children in an integrated manner. Effects are expected to disrupt the reciprocal relations that perpetuate maternal and child mental health problems over time.